University of Michigan (UM) HEAL Initiative National K12 Clinical Pain Career Development Program (UM-HCPDP)

PROJECT SUMMARY / ABSTRACT
This revised application is for an Administrative Supplement to the University of Michigan (UM) HEAL Initiative
National K12 Clinical Pain Career Development Program (UM-HCPDP), (K12NS130673). Last year, we
received a supplement to the parent award to add a 4th scholar slot to the year 2 cohort (each scholar is
supported for up to 3 years). However, due to the parent K12 award being a Type 4 mechanism, the original
supplement could only support the 4th scholar for 1 of the 3 years. Now that the parent award has been
approved for the remaining years (i.e., years 3-5), with this revised supplement application, we are seeking
years 2-3 of support for the 4th scholar slot of cohort 2 as well as the funding for a 4th scholar slot in years 3-5
of the parent award.
The short-term goal of this revised administrative supplement is to provide increased opportunities for training
within our existing HEAL National K12 program. The long-term goal is to develop a diverse clinical pain
research workforce that has the skills and content expertise needed to address the existing gaps in clinical
pain science. Our National K12 Program, funded via the HEAL Initiative, began in October of 2022 and seated
its first class of three scholars in June 2023. This first round of applications had far more qualified applicants
than could be accommodated by our existing 3 training slots. In order to keep pace with the demand for better
pain care we needed to both expand the number of scientists who are capable and knowledgeable about the
complexities of pain as well as the breadth or diversity of expertise that can be brought to the table to inform
novel treatments.
With the original supplement, we received the first year of funding for a 4th scholar slot of cohort 2. Now that
the parent award has been approved for years 3-5, we are seeking the remaining funding to support the
addition of a 4th scholar slot to each of the remaining years of the award.
Impact: The impact of adding 1 additional training slot per year will expand the clinical pain research workforce
as well as help to diversify the workforce for greater impact.

Public health relevance
PROJECT NARRATIVE The overall goal of the proposed University of Michigan (UM) HEAL National K12 Clinical Pain Career Development Program (UM-HCPDP) is to develop a national training program for early career clinician- scientists so as to grow the next generation of clinical pain research scholars. This national K12 program develops guidelines for career development and mentoring in clinical pain research, and coordinates training for scholars across institutions and mentorship teams, and with the Coordinating Center for National Pain Scientists Program (CCNPS). The UM-HCPDP seeks to train clinician-scientists with a deep understanding of pain mechanisms, non-opioid treatment options, scientific methodological rigor, leadership, patient-centric perspectives, and compassion for those who are suffering. This supplement seeks to expand the number and diversity of clinical pain research scholars entering the field of pain research.